Regulation of neuronal function by mitochondrial uncoupling

PROJECT SUMMARY / ABSTRACT
Obesity is a major contributor to the epidemic of metabolic diseases including type II diabetes, hypertension,
cardiovascular disease, and liver disease. Excess weight gain is the result of a chronic imbalance between
caloric intake and energy expenditure, and while several pharmacological agents target energy intake to promote
body weight loss, no current options are successful in the long-term management of obesity. Thus, a greater
understanding of the central mechanisms that contribute to obesity are required for both its prevention and
treatment. Numerous studies have implicated mitochondrial dysfunction in neurons because of excess
consumption of nutrients in the pathogenesis of obesity. Previous publications have demonstrated that the inner
mitochondrial membrane protein uncoupling protein 1 (UCP1), renowned for its role in heat production in
thermogenic adipose tissue, is also expressed in the central nervous system (CNS), however, the function of
neuronal UCP1 is completely unknown. Our preliminary data unexpectedly demonstrates that UCP1 is
expressed in the ventromedial hypothalamus (VMH) of adult mice and that its expression is metabolically
regulated. Consequently, there is a need to understand how UCP1 functions and whether it’s activation within
the CNS can also regulate energy homeostasis as it does in brown adipose tissue. The next steps addressing
these needs are to pursue the overall objective of this application: (i) determine the extent to which UCP1 in
the VMH influences energy balance, and (ii) investigate if neuronal UCP1 activity attenuates the production of
reactive oxygen species (ROS) to regulate energy homeostasis. We will investigate our central hypothesis that
activation of UCP1 within the VMH chronically reduces ROS to promote negative energy balance. We will test
our hypothesis using novel genetic mouse models and viral vector constructs that knockout or overexpress UCP1
specifically in the VMH to determine whether modulation of neuronal UCP1 activity regulates body weight
following cold exposure or consumption of high fat diet. Moreover, we will be able to investigate whether UCP1
in the VMH can chronically reduce ROS to regulate energy homeostasis, as well as determine how modulating
its expression regulates mitochondrial dynamics. The experiments proposed in this application are expected to
identify novel signaling pathways that provide new insights into the treatment and prevention of obesity.
Rationale for this project is that discovering the function of central UCP1 may contribute to future discovery
efforts to identify and test new therapeutic targets to treat obesity. In addition, an outlined career development
plan to elevate my knowledge of mitochondrial biology by leveraging mentorships, technical training, seminars,
conferences, and R01 workshops is described in the application. The University of Iowa has committed its
support and facilities to allow Dr. Claflin to complete the proposed research and participate in their extensive
training seminars. Completion of the proposed 5-year research and training plans will prepare Dr. Claflin for an
independent research career and assist in securing an R01 from the NIDDK.

Public health relevance
PROJECT NARRATIVE According to the CDC, obesity has reached epidemic proportions, with over 60% of the U.S. population being overweight or obese, thus, there is a serious demand for the development of new therapeutics to combat obesity and its sequelae. Excess weight gain leads to dysfunction of mitochondria, essential organelles that convert ingested nutrients into energy that can be used by the body. Mitochondrial dysfunction within the brain is especially detrimental as the brain is critically involved in the regulation of body weight, therefore, by investigating mechanisms that can improve mitochondrial function in the brain, I hope to discover a novel, effective and safe target for the treatment of obesity.